SAFETY, TOLERANCE OF RHHUIL-10 IN PATIENTS WITH ACTIVE CROHN'S DISEASE

The purpose of the study is to study the efficacy, safety and tolerance of multiple doses of subcutaneous SCH 5200 in patients with chronically active Crohn's Disease.